Non-human-primate core for translational vaccine research

Core 2. Nonhuman Primate Core
Project Summary/Abstract
The goal of Scientific Core 2, the Nonhuman Primate Core of the “Immunization against Multidrug-resistant
Pathogens: Activating T Cell Immunity” Center of Excellence for Translational Research (IMPACT-CETR), is to
provide and perform studies with Macaca mulatta (Rhesus macaques) for vaccine candidates developed by the
research projects. Nonhuman primates (NHP) are widely used as a prospective disease model for pathogenesis
studies induced by experimental infection and as means to produce host response for immunogenicity and
protective efficacy of vaccine candidates. Scientific Core 2, located at the Tulane National Primate Research
Center, will focus on the judicious and thoughtful use of rhesus macaques in the proposed studies, and will
address the technical rubrics that may be encountered during vaccine development and testing. It will provide
the required significant planning, expert involvement, and thoughtful performance of requisite steps to ensure
the best use of a critically precious scientific resource. Aim 1 is to characterize host immune response and
prevailing pathophysiology of baseline infection with either phenotypic or resistant strains of the selected
bacterial pathogens in immunocompetent, naïve rhesus macaques. Aim 2 is to evaluate immunogenicity and
efficacy of vaccine candidates in NHPs. Scientific Core 2 will generate expert test systems for subsequent
vaccine candidate evaluation and may yield novel tractable strategies for future medical countermeasure
development and optimization.